Improving value-based healthcare delivery for opioid use disorder

Project Summary
Opioid use disorder (OUD) is an increasingly common cause of death, disability, and cost to the healthcare
system. Though evidence-based OUD treatment exists, uptake is often poor; and those with OUD frequently
have profound health-related social needs that complicate their care. Improving OUD outcomes depends not
only on treatment efficacy, but also on optimizing the healthcare delivery and payment systems in which
efficacious treatments are deployed. Value-based care – a healthcare delivery and payment model that aims to
incentivize value rather than volume of care – represents a widespread approach to healthcare reform touted
for its potential to improve OUD care processes and outcomes. Despite this promise, however, large
knowledge gaps remain in our understanding of whether – and how – value-based care may promote quality
care for people with OUD. This K01 proposal therefore leverages an opportunity to assess the effectiveness of
value-based care delivery for OUD in the context of Massachusetts’ implementation of an innovative new
Medicaid accountable care organization (ACO) model of care. The Massachusetts Medicaid ACO program is
the first of its kind to base ACO payments not only on beneficiaries’ medical complexity, but also on behavioral
health and social complexity. The research aims are to use implementation of this novel ACO program as a
natural experiment to 1) assess the impact of value-based care reform on OUD care quality, 2) understand
whether current risk adjustment methods for setting ACO payments adequately cover costs of care for socially
complex patients with OUD and housing instability, and 3) develop a pilot risk adjustment model for OUD care
quality measures. The Principal Investigator, Dr. Heather Hsu, is an early career clinician-investigator with prior
research experience at the intersection of infectious disease epidemiology, health services research, and
value-based care. With this K01, she seeks to transition the clinical focus of her research to substance use,
focusing on developing content expertise in addiction healthcare delivery and advanced methodologic skills in
quasi-experimental study design and risk adjustment for quality and payment. Dr. Hsu will acquire these skills
and conduct the proposed research at Boston Medical Center and Boston University School of Medicine,
national leaders in addiction medicine and research and home to the largest group of Medicaid ACOs in
Massachusetts. The proposal is supported by an interdisciplinary mentorship and advisory team with expertise
in addiction medicine, substance use research, social determinants of health, advanced methods for causal
inference, health economics, econometrics, and risk adjustment. Training will be accomplished through an
intensive combination of formal coursework, workshops, field experience, applied research experience, guided
tutorials, and focused mentorship. At the end of the K01 award period, Dr. Hsu will be well-positioned to
accomplish her long-term goal to become an independent investigator and expert on improving value-based
healthcare delivery to persons with substance use disorders.

Public health relevance
Project Narrative Improving opioid use disorder outcomes depends not only on developing evidence-based treatments and prevention strategies, but also on optimizing the healthcare delivery and payment systems in which these interventions are deployed. Though value-based care is one of the most widespread healthcare delivery system innovations in the US today, large knowledge gaps remain in our understanding of whether – and how – these models promote better care quality for people with opioid use disorder. This career development award application proposes to use Massachusetts Medicaid accountable care organization implementation as a natural experiment to understand the effect of value-based care reform on quality of care and adequacy of reimbursement for opioid use disorder.